Lymphatic Dysfunction in the Pathogenesis of COPD

Project Summary/Abstract
Chronic Obstructive Pulmonary Disease (COPD) is a destructive inflammatory lung disease that is the 4th leading
cause of death in the U.S., killing more than 150,000 people yearly. Current therapies can improve symptoms
and reduce hospitalization, but none modify this disease or stop its relentless progression. COPD is commonly
caused by cigarette smoke (CS), but we do not yet fully understand the early events that trigger inflammation
and tissue destruction that could be intervened upon to halt the cycle of lung injury. This knowledge gap has led
to an absence of disease-modifying therapies and a therapeutic pipeline that has thus far led to only incremental
advances on existing drugs. The lymphatic vessels are uniquely positioned to regulate inflammatory responses
in most tissues because they drain fluid and traffic immune cells in the form of lymph. We have recently published
our findings that impaired lymphatic drainage alone is sufficient to induce lung inflammation that culminates in
the hallmarks of human COPD. Furthermore, we have discovered that lymphatic endothelial cell injury and
lymphatic vessel thrombosis are early events after CS exposure. Interestingly, we not only identified lung
lymphatic thrombosis in human lung tissue from patients with COPD, we also found that the degree of lymphatic
thrombosis is linked to COPD severity. This work suggests that lymphatic dysfunction may be central to COPD
pathogenesis but the role of the lymphatics in CS-induced lung injury and inflammation is not well understood.
Filling this critical knowledge gap promises to result in new classes of lymphatic-targeted agents that have the
potential to block or reverse COPD and lead to prolonged survival in these patients. We will investigate the novel
concept that lymphatic dysfunction is a defining early event in the pathogenesis of emphysema that can
contribute to progressive tissue destruction. Therefore, the objective of this proposal is to define the
actionable mechanisms that result in lymphatic endotheliopathy after CS exposure and drive
progression of COPD. Our central hypothesis is that lymphatic thrombosis due to CS drives disease
progression through activation of thrombin in the lymphatic endothelium. Our approach consists of lymphatic-
specific manipulation of the coagulation pathway and thrombin signaling in order to mechanistically address the
consequences of lymphatic thrombosis on disease progression in a murine model of COPD (Aim 1), and the
mechanism by which CS causes lymphatic dysfunction (Aim 2). Furthermore, we will use these models to test
how inhibition of thrombin activity or specific inhibition of the thrombin receptor affects the inflammatory response
to CS and disease progression. When completed, these studies will lead to a shift in the current paradigm for
the pathogenesis of COPD to include early changes in lung lymphatic function. In doing so, we will both broaden
the field and set the stage for further studies with immediate clinical relevance given the use of existing therapies
to target lymphatic function.

Public health relevance
Project Narrative Chronic Obstructive Pulmonary Disease (COPD) affects over 14 million individuals in the United States, but the underlying factors that determine why some individuals develop progressive COPD while others do not have not been fully elucidated. This proposal will determine how injury and clot formation in specialized vessels called the lung lymphatics are early and defining events in the pathogenesis of COPD that contributes to disease progression. We will also test how existing drugs can be used to target the lymphatics for therapy in COPD.